Clinical Studies NCORP Boot Camp Program for Early-Career Investigators

Administrative Supplement to UG1 CA189824 in response to NOT‐OD‐22‐057
Project Summary Supplement: The Wake Forest NCI Community Oncology Research Program
Research Base (WF NCORP) is committed to training the next generation of Cancer Control and
Cancer Care Delivery Research (CCDR) investigators. WF NCORP MPIs (Lesser & Weaver) and
leaders supported by this supplement (Dressler, Klepin, & Strom) are experienced research
mentors, including mentoring experience with trainees traditionally under-represented in
biomedical research. Through this supplement, our team will build on current mentoring activities
in the parent award to expand mentoring opportunities for new NCORP investigators who are
members of groups underrepresented in the biomedical research enterprise by adapting a
successful Clinical Trials Boot Camp program developed by Dr. Dressler for the WF
Comprehensive Cancer Center (WF CCC). The new NCORP Boot Camp program will facilitate
the research success of participants by enhancing their access to mentoring, pilot grant funds,
and grant writing skills, with the ultimate goal of enhancing the diversity, equity, inclusion, and
accessibility (DEIA) of WF NCORP study PIs and the WF NCORP leadership pipeline.

Public health relevance
Administrative Supplement to UG1 CA189824 in response to NOT‐OD‐22‐057 Project Narrative: The Wake Forest NCORP Research Base develops and implements multi‐site Cancer Control and Cancer Care Delivery (CCDR) clinical research studies in partnership with NCORP Community and Minority/Underserved Community Sites to improve patient well‐being and the quality of cancer care.